Molecular Biophysics Training Program

The University of Texas Southwestern Medical Center (UTSW) Molecular Biophysics T32 Training Program (MB-T32) aims to develop a robust cohort of PhD students immersed in cutting-edge biophysical concepts and methodologies, for successful biomedical research careers. Combining group initiatives and individualized programming that emphasizes deep understanding, rigorous research practices, safety, and ethics, MB-T32 is designed to nurture emerging and ethical scientists with advanced biophysical research skills. Building upon successful elements of the current program (coursework, training activities, Responsible Conduct of Research training and career development support), we will add new training elements to capitalize on emerging opportunities and address local challenges. The field of biophysics is undergoing rapid change, posing a challenge to stay current in educating and training new biophysicists, especially with the UTSW biophysics community distributed across two campuses and thirteen departments. MB-T32 will meet this challenge by becoming the central, driving force for innovating biophysics education and training across UTSW to ensure trainees receive an up-to-date foundational biophysics education prior to MB-T32 training that will expose them to more cutting-edge topics. MB-T32 coursework will deliver tailored education to each trainee based on their specific biophysical and biomedical interests while activities will promote cohesion and breadth of knowledge. Recruiting is another challenge that MB-T32 addresses in this application: the relatively small population of quantitative biophysicists at UTSW is not meeting the growing demand. By spearheading recruitment of talented biophysics students, MB-T32 will shape the future of this field on campus and more broadly. MB-T32 is committed to cultivating a supportive training environment, showing respect for our trainees and empowering them to develop agency and independence through collaborative leadership opportunities. New activities will facilitate personalized monitoring of trainee progress and interventions, expand the mentoring network, and address challenges related to differences in academic preparations in quantitative sciences, rapid advancements in biophysics, and the lingering effects of the pandemic on social cohesion. MB-T32 is poised to empower the next generation of biophysicists to confront the most pressing questions and challenges in biomedical research.

Public health relevance
This proposal describes a molecular biophysics training program at UT Southwestern to develop a group of talented PhD students into rigorous and ethical experts in biophysical and quantitative methodologies and concepts. Through rigorous, personalized coursework and collaborative training, students will develop the skills to address the most pressing biomedical challenges that impact human health and disease, work effectively in interdisciplinary teams, and communicate their research clearly – preparing them to contribute meaningfully to public health through careers in biomedical research. The program will remain at the forefront of biophysics training by continuously updating its curriculum to reflect emerging methodologies and by recruiting outstanding quantitatively oriented students, building a next-generation workforce ready to confront the most critical problems in biomedical research and public health.